Vestibular and Visual Control of Eye Movement

PROJECT SUMMARY
A hallmark of the nervous system is its ability to transform and combine multiple sources of information to guide
behavior, and to tune this signal processing through learning, for more accurate control of behavior. How this
adaptive signal processing is implemented by neural circuits remains largely unknown, due in part to the
presence of feedback loops that mix together and temporally shape neural signals in complex ways. This project
uses an interdisciplinary experimental-computational approach to dissect the signal processing operations
supporting the control of eye movements by vestibular and visual sensory inputs. Rigorous experimental
protocols, computational models, and statistical fitting approaches will be developed to characterize the signal
transformations occurring at multiple sites in the relevant neural circuitry, to disentangle the roles of feedforward
and feedback signals in the control of eye movement behavior. These approaches will be used to analyze how
specific changes in the way vestibular and visual signals are processed by the circuit support adaptive changes
in the amplitude and timing of the eye movement responses to these sensory inputs. By advancing our
understanding of how learning alters the way a circuit computes, this work bridges the key conceptual gap
between neural plasticity at the synaptic level and learning at the behavioral level, and provides a scientific
foundation for the development of improved clinical approaches for promoting recovery or replacement of
vestibular function.

Public health relevance
PROJECT NARRATIVE The vestibular system plays a key role in our ability to move and interact with the world, by supporting balance, posture, and the stabilization of vision during movements of the head and body. This project will provide insights about the computations neural circuits perform on vestibular signals to guide movements, and how those computations are tuned by learning. The results will build a foundation to guide the development of new approaches for treating balance disorders.